DP19-001, Health Promotion and Disease Prevention Research Center

PROJECT SUMMARY/ABSTRACT
The obesity epidemic continues to worsen, with low-income and rural populations as well as African
American women disproportionately affected. Using community-based participatory research, the
Emory Prevention Research Center has developed and rigorously tested an intervention to create
home food environments that support healthy eating and weight gain prevention with partners in rural
southwest Georgia (SW GA). The proposed core research is a hybrid effectiveness-implementation
study of this intervention, called Healthy Homes/Healthy Families, delivered through a regional 2-1-1
system. 2-1-1 is a nationally designated 3-digit telephone exchange, similar to 9-1-1, that links callers
to community-based health and social services. Our long-term goal is to leverage this collaborative
infrastructure to address the obesity epidemic and scaling up of effective interventions through the
national 2-1-1 system. Callers to 2-1-1 are disproportionately low-income, unemployed, uninsured, and
have fewer years of education relative to the general population. Specifically, in collaboration with
community partners in rural SW GA and four United Way 2-1-1 partners, we propose to conduct a
hybrid effectiveness-implementation trial and scalability assessment to rigorously assess: a) the impact
of a telephone-based home food environment intervention on weight-related dietary behaviors, b)
implementation outcomes (i.e., reach, acceptability, barriers and facilitators), c) cost-effectiveness, and
d) the scalability potential of a regional 2-1-1 system to deliver Healthy Homes/Healthy Families and
other evidence-based cancer prevention interventions. We are uniquely positioned for this research
given our long-standing track record in collaborating with 2-1-1s in disseminating research-tested
interventions across multiple states and our expertise in implementation science. This novel approach
to translational research, in combination with plans for broader faculty engagement across Emory
through a multi-disciplinary Internal Advisory Board, a Stakeholder Advisory Board for Translation with
nontraditional partners including United Way agencies and Cooperative Extension, and a deeply
engaged Community Advisory Board in rural SW GA, position the EPRC to be a major player in
prevention research with clear relevance for public health practice in Georgia and beyond. Nationally,
we will establish a model for taking interventions developed through CBPR to scale through existing 2-
1-1 systems. This model of developing interventions locally in SW GA through CBPR and then scaling
up with an innovative translation partner, such as 2-1-1, is a promising model with significant potential
for translating public health interventions into practice for population-level impact.

Public health relevance
PROJECT NARRATIVE Preventing weight gain in adults through modest changes in the home food environment has the potential to be an important strategy for addressing the obesity epidemic. This implementation research will establish a model for scaling up interventions developed through community-based participatory research through a regional 2-1- 1 system that reaches those most at risk for obesity.